G6PD Deficiency and Atherosclerosis

Glucose-6-phosphate dehydrogenase deficiency (G6PD-d) is the most common enzymopathy,
affecting approximately 5% of humans, or half a billion individuals worldwide. While the majority
of data centers around the erythrocyte phenotype in G6PD-d with hemolysis being a notable
and impactful result of G6PD-d, this deficiency exists in all cell types. Recent epidemiological
data suggest that G6PD-d in humans may be associated with increased risk of CVD. Yet
whether G6PD-d plays a causal role in atherosclerosis development is unknown. Our
preliminary data, utilizing a novel humanized mouse which expresses a human G6PD gene with
a common G6PD-d mutation (Med-), revealed a significant increase in diet-induced
atherosclerosis in the G6PD-d mice compared to the canonical control. Intriguingly, immune cell
profiling of these mice revealed a significant reduction in atheroprotective B-1b cells and the
IgM to oxidation specific epitopes (OSE) that they make. In mice, B-1b cells protect against
atherosclerosis largely through production of IgM antibodies that block these pro-inflammatory
OSE on LDL (IgMOSE). Humans with high levels of IgM to OSE have less coronary artery
disease (CAD) and fewer CV events. Yet, the factors that regulate these atheroprotective IgM
producing cells are largely unknown. Accordingly, we propose to test the hypothesis that G6PD-
d promotes atherosclerosis, at least in part, through B cell intrinsic effects of G6PD-d on B cell
subset number and production of IgM to OSE.

Public health relevance
Project Narra�ve We provide the first evidence that mice with G6PD deficiency (G6PD-d) due to a genetic variant have increased atherosclerosis compared to control mice. We identified atheroprotective B cell subtypes and IgM to oxidation specific epitopes as key factors limited by G6PD-d. We will employ innovative humanized murine models to define mechanisms whereby G6PD-d alters B cell biology and to determine if other non-B cell-mediated processes altered by G6PD-d are also involved. These studies are expected to steer the field of nonmalignant hematology in new directions and carry high potential to open new pathways for prevention and treatment of cardiovascular disease, the leading cause of death worldwide.